5-HT1A RECEPTOR INVOLVEMENT IN THE CONTROL OF FEMALE SEXUAL BEHAVIOR

The proposed research is designed to identify the CNS site(s) responsible for the inhibition of female rat sexual behavior after treatment with the 5-HT1A agonist, 8-hydroxy-2-9(di-n-propylamino)tetralin (8-OH-DPAT). Activation of somatodendritic 5-HT1A autoreceptors by 8-OH-DPAT decreases the firing of 5-HT neurons and reduces the release of 5-HT in regions innervated by these neurons. In terminal fields, the 5-HT1A receptor exists at postsynaptic sites. Although it may also reside on presynaptic terminals, the 5-HT1A receptor does not function as the terminal autoreceptor. The specific aims of the proposed studies are: (1) to identify the neural areas sufficient for the inhibition of female sexual behavior following treatment with 8-OH-DPAT and (2) to compare the effectiveness of this 5-HT1A agonist with that of other 5-HT1A agonists and 5-HT1B-preferring agonists. The effects of putative 5-HT1A antagonists will also be studied. Intact, regularly cycling female rats will be used and special emphasis will be placed on differentiating the postsynaptic effects of 8-OH-DPAT from those mediated by its action at the serotonin cell bodies. 8-OH-DPAT will be infused intracerebrally into the medial basal hypothalamus and medial preoptic area, terminal fields that control female reproduction, and into the dorsal raphe nucleus, which contains 5-HT cell bodies. Sexual behavior will be monitored before and after infusion. these studies will provide an opportunity for MBRS students to learn neuroanatomical, neurochemical, and behavioral methods in the neurosciences.